Optimizing Patient-Centered Opioid Tapering with Mindfulness-Oriented Recovery Enhancement

Patients with chronic pain are commonly treated with long-term opioid therapy (LTOT) despite risk of opioid-
related harms including increased pain sensitivity, opioid misuse, overdose, and opioid use disorder (OUD).
The risks of LTOT may outweigh its benefit for some patients. For instance, approximately 25% of individuals
receiving LTOT for pain engage in opioid misusing behaviors such as unauthorized dose escalation or using
opioids to alleviate negative emotions. Because opioid misuse confers risks for a range of other opioid-related
harms, patients showing signs of opioid misuse need safe, flexible patient-centered opioid tapering approaches
to reduce these risks. Patient-centered opioid tapering may be facilitated by adjunctive behavioral
interventions. However, due to the complexity of the pathogenic mechanisms fueling the downward spiral from
chronic pain to opioid misuse and OUD, few interventions have been shown to be efficacious in facilitating
opioid tapering and safely reducing opioid-related harms among people with LTOT. Extant therapies may have
limited efficacy because they fail to directly remediate dysregulation of brain reward systems underpinning this
downward spiral of behavioral escalation. To address this gap, through a NIDA-funded integrative behavioral
treatment development process we translated mechanistic findings from affective neuroscience into an
innovative treatment for opioid misuse and chronic pain, called Mindfulness-Oriented Recovery Enhancement
(MORE), that aims to enhance cognitive regulation of reward processes. In multiple randomized controlled
trials (RCTs) patients treated with MORE reduced opioid dosing and opioid-related harms while evidencing
improvements in chronic pain and quality of life. This opioid dose reduction was patient-initiated and occurred
without explicit guidance from a physician. MORE has not yet been tested in combination with an explicit
patient-centered opioid tapering protocol. Given its demonstrated efficacy as a standalone intervention, we
hypothesize that adding MORE to patient-centered opioid tapering will robustly reduce opioid-related harms
while simultaneously improving chronic pain and quality of life. In ten primary care clinics in New Jersey and
Utah we propose to conduct a hybrid 2 implementation-effectiveness RCT of MORE as delivered via an
economically sustainable, insurance-reimbursable group medical visit (our key implementation strategy) as an
adjunct to a patient-centered opioid tapering protocol that leverages patient agency and therapeutic
expectancy. Given significant population differences between New Jersey and Utah, this study will maximize
geographic and racial/ethnic diversity and provide high generalizability of findings. Informed by patients with
lived experience, our trial design will determine whether the MORE plus patient-centered opioid tapering
intervention can be implemented with effectiveness and fidelity by community providers, and will evaluate the
implementation elements and intervention cost effectiveness that influence its uptake in the community.

Public health relevance
PROJECT NARRATIVE Patient-centered opioid tapering might be facilitated by behavioral interventions that address the factors driving the downward spiral from chronic pain to opioid misuse. The overarching goal of this proposal is to test whether adding Mindfulness-Oriented Recovery Enhancement to patient-centered opioid tapering can reduce opioid-related harms and chronic pain while improving quality of life among patients in primary care.